Impact of alternative payment models on specialist care for patients with new-onset end-stage renal disease

Project Summary Background: End-stage renal disease (ESRD), which affected >746,000 Americans in 2017, is the final stage of chronic kidney disease, leading to death unless renal replacement therapy is initiated. Of the treatment options available (in-center hemodialysis, home dialysis, kidney transplantation), transplantation is the preferred modality, offering the best survival time, quality of life outcomes, and lowest average cost. Home dialysis modalities are also less costly than in-center dialysis and associated with improved patient satisfaction. Despite these advantages, <15% of incident ESRD patients received home dialysis or a living donor kidney transplant in 2016, and only 14% of patients joined a transplant waiting list or received a transplant within one year of initiating treatment. The Advancing American Kidney Health initiative (July 2019) proposes to enroll 50% of ESRD care providers in a shared-risk alternative payment model (APM) that would tie providers' payment to cost savings on health service use, with the goal of increasing use of cost-effective treatments (home dialysis and transplantation). Currently, no evidence exists about nephrologist participation in APMs, or their impact on treatment outcomes in specialty care. This study will examine nephrologist participation in two shared-risk APMs (accountable care organizations [ACOs] and ESRD seamless care organizations [ESCOs]), to characterize the population of APM-affiliated nephrologists and estimate the impact of nephrologist APM affiliation on treatment use and clinical outcomes for patients with new-onset ESRD. Data: This project will link 11 years (2006-2017) of United States Renal Disease System data—rich clinical and administrative data for >1,250,000 incident ESRD patients and >7,500 dialysis facilities—to provider-level data on ACO (Medicare Shared Savings Program Provider-level files) and ESCO participation (provider-level public data). Several additional public data sets (e.g., US Census Bureau, CMS Hospital Compare) will supplement the provider- level dataset with facility and community characteristics. Analysis: Aim 1 will test associations between APM affiliation and nephrologists' key geographic, sociodemographic, and facility characteristics using logistic regression models. Aim 2 will estimate the impact of nephrologist APM participation on treatment use and ESRD patient health outcomes using rigorous quasi-experimental methods (difference-in-difference regression), comparing nephrologists' treatment use and patients' outcomes before and after APM affiliation, relative to contemporary changes in these outcomes among never-affiliated nephrologists during an 11-year period of widespread APM adoption. Implications: APM participation will be mandatory for half of ESRD care providers in 2020. This research will provide foundational information about nephrologists that have been affiliated with APMs to date and about the impact of APM affiliation on treatment use and health outcomes for patients with new-onset ESRD. Importantly, this study's findings will inform broader policy and health systems deliberations about the design and implementation of APMs in specialty care settings.

Public health relevance
Project Narrative Participation in a new alternative payment model (APM) intended to incentivize use of high-value care (transplant and home dialysis) for patients with end-stage renal disease (ESRD) will be mandatory for half of ESRD care providers in 2020. Using rich clinical and administrative claims data on >1,240,000 patients with new-onset ESRD and >7,500 US dialysis facilities over an 11-year period of widespread APM adoption (2006- 2017), this study will estimate the impact of nephrologists' participation in existing APMs on treatment use and key health outcomes for patients with new-onset ESRD. This study's findings will provide the first evidence on the characteristics of APM-affiliated nephrologists and the impact of APM affiliation on treatment use and patient health outcomes in ESRD care, and importantly will inform broader policy debates about the design and implementation of APMs in specialty care settings.